The Use of Virtual Reality to Discover Objective Correlates of Alcohol Craving

PROJECT SUMMARY
The study of craving for alcohol and drugs is increasingly thought to be essential for understanding the
pathogenesis and maintenance of addiction. However, valid and reliable methods for investigating this
psychobiologic phenomenon are lacking. This study seeks to develop a novel, ecologically valid paradigm that
capitalizes on the technological advances and realism of virtual reality (VR) to both induce alcohol craving, via
presentation of realistic alcohol-related cues, and reliably assess alcohol craving, via measurement of potential
craving correlates (attentional bias and spontaneous eye-blink rate [EBR]) and subjective reports. Following
initial acceptability testing and optimization (n=15), three alcohol active and three neutral VR scenes will be
administered to a sample comprised of low-moderate alcohol drinkers (n=50) and heavy alcohol drinkers
(n=50). Eye-tracking (to establish attentional bias towards alcohol cues) and EBR will be continuously recorded
during presentation of the scenes. Participants will then be followed for seven-days, via mobile assessment,
and contacted by phone at day 30, to obtain self-report responses of subjective alcohol craving and alcohol
use in their naturalistic environment.
Thus, the specific aims of the proposed research are: (1) to develop an ecologically valid and immersive
VR cue-reactivity paradigm that reliably induces alcohol craving, (2) test the feasibility, reliability, and utility of
VR derived attentional bias as an objective craving correlate by comparing it against commonly used measures
of subjective craving and attentional bias, and (3) examine the predictive utility of the objective correlates of
alcohol craving acquired during the paradigm and subjective reports of alcohol craving and alcohol use during
follow-up. The use of EBR as an objective craving correlate will also be investigated as an exploratory aim.
Once fully developed and tested, this paradigm will have tremendous applications within basic science
research on alcohol craving and within clinical science via providing a new platform to develop interventions
that aim to reduce craving. Further, this project will advance our understanding of attentional bias and its utility
as a predictive measure of alcohol craving and use.

Public health relevance
PROJECT NARRATIVE This project seeks to increase our ability to accurately and reliably assess the clinically important construct of alcohol craving. Potential psychobiologic correlates of alcohol craving will be investigated which, if deemed reliable, may provide a much needed objective marker of craving to the field of addiction science. Further, the development of an ecologically valid virtual reality cue-exposure paradigm will advance our ability to induce craving in the laboratory and provide a platform by which future craving-related interventions can be tested.